E-Cigarette Use among U.S. Adolescents and Young Adults: Longitudinal Associations with Tobacco Use and Health and Dimensions of Risk and Protection

One-third of U.S. adolescents and young adults (AYAs) report e-cigarette (EC) use, making it the leading nicotine/tobacco product used by AYAs. Most longitudinal studies of e-cigarette use only focus on short-term outcomes 1-3 years later, do not fully examine newer vs. older generation e-cigarette products. Potential bias in e-cigarette estimates over time is not well understood. These gaps warrant longer-term prospective investigations with clinically relevant measures in national samples of AYAs. This project will identify longitudinal trajectories of e-cigarette use and their relationships with cigarette smoking, other nicotine/tobacco products, other substance use, tobacco use disorder (TUD) symptoms, nicotine/tobacco cessation, and health consequences related to nicotine/tobacco use among U.S. AYAs. Our study aims to: (1) Compare state-of-the-art statistical approaches for reducing nonresponse bias in estimates of trajectories and survival models for EC use due to differential attrition, and evaluate the reporting bias associated with self-reports of EC use using biomarker data; (2) Examine the initiation of e-cigarette use and transitions with other nicotine/tobacco product use and other substance use in AYAs over 4- and 7-year time periods of longitudinal data; (3) Identify the trajectories of EC, cigarette, and other tobacco use and their longitudinal relationships with adverse health consequences (e.g., TUD symptoms, health problems) measured with survey and biomarker data in AYAs over 4- and 7-year time periods, and determine if trajectories or consequences differ by type of EC product; and (4) Based on the Social Ecological Model, assess multiple levels of risk and protective factors (and interactions across levels) for EC use trajectories and their associations with other nicotine/tobacco use, tobacco cessation, and health consequences over 4- and 7-year time periods, and examine if EC use trajectories and their associations with other nicotine/tobacco use, tobacco cessation, and health consequences differ by type of EC product. An experienced team will conduct secondary analyses of longitudinal data from the Monitoring the Future (MTF) and Population Assessment of Tobacco and Health (PATH) studies. These two epidemiological studies are the most recent and largest nationally representative longitudinal studies that allow for the identification of long-term trajectories and consequences of EC use among AYAs. This project will use longitudinal data from a nationally representative sample of 9,800 secondary students measured between 2014 and 2020 in the MTF study, and a prospective nationally representative sample of 13,651 adolescents (12-17 years), 9,802 young adults (18-25 years), and 22,506 adults (26 and older) measured across six waves in the PATH study (2013/2014-2020).

Public health relevance
Although one in every three U.S. high school seniors used e-cigarettes in the past year, the long-term trajectories and consequences of e-cigarette use, and longitudinal associations with other nicotine/tobacco use, tobacco cessation, tobacco use disorder symptoms, and other health consequences beyond 1-3 years remain largely unknown. This study will address these critical gaps in public health knowledge by improving estimates of e-cigarette use trajectories, investigating the long-term health consequences associated with trajectories of e-cigarette use among adolescents and young adults, and identifying important risk and protective factors for e-cigarette use and its negative health consequences. Findings from the proposed longitudinal study will be widely disseminated to help guide clinical practice, inform public health policies, and enhance future longitudinal research to reduce tobacco-related harms.